Novel neural activity imaging platform to discern sex hormone control of sexually dimorphic pain processing

Project Summary
Novel neural activity imaging platform to discern sex hormone control of sexually dimorphic pain processing
The lack of research on female physiology has led to a failure in the translation of therapeutics for women,
especially across chronic and neuropathic pain conditions. Understanding the structural and functional
differences between female and male pain systems is essential for developing sex-specific medical
interventions. However, the complexity of these systems combined with the limitations of current technologies
to assess neuronal activity prevent a complete view of sex-based pain processing. To address this gap, we
propose a proteomic approach for high-throughput, multiplexed spatial analysis for single-cell neural activity
sensing, signaling, and identity across nervous tissues that will advance our understanding of sex-based pain:
MINDMAP (Mass cytometry Imaging of Neural activity by immediate early gene Detection with simultaneous
Multiplexed marker Analysis Platform). This novel neural activity sensing platform is based on imaging mass
cytometry – a tissue staining variant capable of 40+ protein measurements by antibody-based rare earth metal
mass spectrometry detection, allowing identification of every neuron type that responds to painful stimuli
(nociceptive population) – while sensing neural activity and reporting key signaling pathways. We will leverage
this imaging platform to determine the role of sex hormones in driving sexually dimorphic nociceptive activity
and behavior. In Aim 1, readout of neural activity sensors will produce molecular fingerprints of activity while
simultaneously profiling cell identity, sex hormone signaling status, and oxidative stress (with RPL 3) in mono-
sex neuronal cultures. Aim 2 will extend this spatial, single-cell neural activity sensing in vivo by combining
genetic, surgical, and hormone treatments to directly assess the role of sex hormones in the structure,
function, and behavior of pain systems. This proposal will have critical positive impact by 1) developing
MINDMAP to revolutionize neural activity sensing and 2) leveraging MINDMAP to uncover the mechanisms of
sex difference in pain perception. MINDMAP will be a crucial method for whole tissue, single cell neural
function analysis, allowing hereto difficult interrogation of all cell types while linking key signaling pathways to
activity, and thus be of broad interest to the neuroscience community. Further, this proposal’s results will
provide evidence that sex hormone signaling governs the sexually distinctive functional and nocifensive
responses to noxious stimuli. These results will identify crucial candidates for sex-specific therapeutics and
interventions for chronic pain formation.

Public health relevance
PROJECT NARRATIVE Project Narrative is not required in this component